Regional Oncology Research Center

The Sidney Kimmel Comprehensive Cancer Center (SKCCC) at Johns Hopkins is dedicated to cancer research, education and training, and patient care, with the overarching goal of creating and applying new knowledge to improve prevention, screening, detection, diagnosis and treatment of cancer in Maryland (the SKCCC catchment area) and throughout the nation and the world. This application seeks continued Cancer Center Support Grant (CCSG) funding for SKCCC Research Programs and Shared Resources (SRs). Since the previous CCSG renewal in 2016, the SKCCC has eliminated three Research Programs and created one new Program. Now, the 285 Members, from 34 academic departments throughout Johns Hopkins University, populate seven Research Programs: the new Cancer Invasion and Metastasis Program, and the established Programs in Cancer Genetics and Epigenetics, Cancer Immunology, Cancer Molecular and Functional Imaging, Cancer Chemical and Structural Biology, Hematologic Malignancies and Bone Marrow Transplantation, and Cancer Prevention and Control. Twelve SRs provide state-of-the-art-or-better support for SKCCC research and researchers. SKCCC science encompasses discovery research into the molecular genetics and epigenetics of human tumorigenesis, clinical trials of new immunotherapies and other cancer treatments, and epidemiologic analyses of lifestyle influences on cancer mortality. Over the past funding period, SKCCC Members were exceptionally productive, authoring 3,775 publications (23% intra-Programmatic, 22% inter-Programmatic, and 66% featuring external collaborators). In the most recent year, SKCCC researchers garnered $78.5 million in peer-reviewed grant support, including $44.9 million from the National Cancer Institute. The SKCCC continued to deliver its science to the bedside. From an average 6,374 new cancer patients treated per year from 2016–2020, an average of 1,647 new subjects were enrolled annually to interventional studies (26% of newly registered cancer patients); therapeutic studies accrued some 17% of cancer patients. In addition, the SKCCC has worked successfully to promote inclusion of underserved patients with cancer in clinical research, yielding a slight increase in underserved population participation in interventional trials (22.3% in 2015 to 25.4% in 2020). Moving forward, the SKCCC plans: (1) to promote new breakthroughs in fundamental cancer research that create paradigm-shifting insights into the nature of human cancers, (2) to translate this pipeline of discovery into practice-changing advances, (3) to enhance the delivery of innovative cancer services throughout the state of Maryland catchment area, and (4) to integrate research training and career development of biomedical scientists and health care professionals into all cancer research endeavors.

Public health relevance
Cancer is a leading cause of death in the United States and throughout the world. Given the tremendous medical advances over the past 50 years since the National Cancer Act of 1971, the United States population's life expectancy has dramatically increased, but because the incidence of most cancers increases with age, cancers have become an even more profound challenge to the United States health care system. To meet these challenges, dedicated cancer research at the SKCCC and elsewhere has generated fundamental insights into the molecular mechanisms that cause human cancers to arise, progress and threaten life, which create new opportunities to improve screening, detection, diagnosis, prevention and treatment.